The Neural Basis of the Positivity Offset as a Mechanism of Avolition in Schizophrenia

PROJECT SUMMARY
Avolition (e.g., reduced motivation and engagement in goal-directed behavior) is a core negative symptom and
one of the strongest predictors of functional disability in schizophrenia. Current psychosocial and
pharmacological interventions are ineffective at treating avolition, largely due to limited understanding of its
underlying mechanisms. Leading conceptual frameworks implicating dysfunctional cortico-striatal interactions
and abnormalities in reward processing have improved the field's understanding of the etiological
underpinnings of avolition; however, this work has not yet led to significant breakthroughs in treatment. These
models assume that the hedonic response is intact in schizophrenia, a theory our lab recently proposed may be
premature. By applying an affective science approach informed by Cacioppo's Evaluative Space Model of
Emotional Experience, we recently demonstrated that abnormalities in emotional experience do contribute to
avolition in schizophrenia, in the form of a reduction in the positivity offset. The positivity offset is an adaptive
function characterized by a greater balance of positive than negative emotion at low levels of arousal, which
promotes motivated behaviors. Preliminary data from our lab indicates that the positivity offset is reduced in
schizophrenia and is associated with clinically rated negative symptoms, suggesting it may offer a novel
explanation for avolition. In the current study, we aim to expand these findings by: 1) identifying the neural
circuits underlying the positivity offset, 2) determining whether the positivity offset is also reduced in the real-
world in schizophrenia, and 3) determining whether reductions in the positivity offset and associated neural
processes predict avolition in everyday life. Specifically, we will use fMRI to measure neural activity during an
emotional experience task to test the hypothesis that reduced activation of the medial prefrontal cortex,
nucleus accumbens, and caudate nucleus is associated with reductions in the positivity offset in schizophrenia.
Additionally, we will examine whether activation in these regions predicts positivity offset reduction and
avolition in the real-world, which will be measured via active and passive digital phenotyping. This approach
addresses the gap in understanding of the affective and neural mechanisms underlying avolition and their
impact on daily functioning. Findings have potential to inform personalized medicine approaches to treating
avolition by identifying specific neural circuits and affective processes that can serve as treatment targets for
pharmacological and psychosocial interventions. Further, few clinical investigators are trained to adopt a
transdisciplinary, multimodal approach to study negative symptoms. The proposed research and training plans
are designed to meet this urgent need in the field, providing the applicant with skills in cutting-edge
neuroimaging and digital phenotyping methods to test hypotheses about the origins of avolition.

Public health relevance
PROJECT NARRATIVE Negative symptoms are the strongest predictor of functional disability in schizophrenia; however, no interventions are ineffective at treating negative symptoms due to poor understanding their underlying mechanisms. The current study will examine the neural basis of emotional abnormalities as a mechanism contributing to negative symptoms in schizophrenia. Findings have the potential to inform novel targets for intervention.